NIAAA LOGISTICAL SUPPORT AND SERVICES

FEDPOINT WILL PROVIDE LOGISTICAL AND OTHER SUPPORT SERVICES FOR THE ADVANCING ADHERENCE TO PRE-EXPOSURE PROPHYLAXIS PREP FOR HIV/AIDS PREVENTION AMONG ALCOHOL-USING POPULATIONS: A NIAAA WORKSHOP, NIH BUILDING 49, CONFERENCE ROOM 1A51-1A59